Effectivenss of an Integrated Treatment to Address Smoking Cessation and Anxiety/Depression in People Living with HIV

ABSTRACT
Although the prevalence of smoking has declined over the past 50 years, large disparities in tobacco use
remain across several subgroups, particularly disadvantaged and health compromised populations.1 Smokers
living with HIV represent a major health disparity population in the United States (US) and the world more
generally, and their unique healthcare needs are not being adequately addressed.2 For people living with HIV,
smoking is related to poorer survival3,4 and among those who are adherent to their antiretroviral treatment
regimens, smoking reduces life expectancy more than HIV.5–7 Major contributing factors to the maintenance
and relapse of smoking among smokers living with HIV include increased exposure to multiple stressors
associated with HIV, which often exacerbates anxiety/depression.8
The proposed intervention is informed, in part, by the success of our recently completed NIDA-funded R34
research project (1R34DA031038-01A1) in which we specified and tested in a small open trial, and then, a pilot
randomized controlled trial (RCT) the feasibility, acceptability and initial efficacy of a 9-session, cognitive-
behavioral-based intervention (named QUIT) to address smoking cessation by reducing anxiety and
depression via specific emotional vulnerabilities (anxiety sensitivity, distress tolerance, and anhedonia). This
intervention was specifically adapted and designed for smokers living with HIV. The results from this study
revealed that, when compared to a brief enhanced treatment as usual control intervention (ETAU), patients
assigned to QUIT achieved higher short-term (end of treatment [EOT]: QUIT: 59% vs. ETAU: 9%) and long-
term (6-month follow-up: QUIT: 46% vs. ETAU: 5%) abstinence rates.9
We now propose to conduct a fully powered, 3-arm efficacy/effectiveness trial. We propose to enroll 180
smokers living with HIV across three implementation sites [(1) Infectious Disease Clinic, Massachusetts
General Hospital (MGH), Boston, (2) Fenway Community Health, Boston, and (3) Thomas Street Health
Center, Houston]. We seek to test the efficacy/effectiveness of the QUIT intervention at increasing point
prevalence abstinence (primary outcome), by reducing anxiety and depression (secondary outcomes), and to
determine if it outperforms an active, credible time-matched control, and a standard-of-care (SOC) control. The
integration of resource utilization and cost-effectiveness analyses and the third SOC control arm support
estimation of cost and effectiveness. If successful, the intervention would be ready for translation studies to
examine implementation and dissemination into “real-world” health, mental health, and social service settings.

Public health relevance
PUBLIC HEALTH NARRATIVE Smokers living with HIV represent a major health disparity population in the United States (US) and their unique healthcare needs are not being met. Building from our successful R34 project (1R34DA031038-01A1), the proposed study aims to address smoking-based health disparity among smokers living with HIV by testing whether our 9-session, cognitive-behavioral-based intervention (Project QUIT), which addresses smoking by reducing anxiety/depression via specific emotional vulnerabilities (anxiety sensitivity, distress tolerance, and anhedonia), outperforms an active, credible time-matched control and a standard-of-care (SOC) control. If successful, the intervention would be ready for translation studies to examine effectiveness and dissemination into “real-world” behavioral health, mental health, and social service settings.